Data Core – Improving Provider Announcement Communication Training (IMPACT)

The Data Core will centralize data-related services across research projects for the P01 Program Project, “Improving Provider Announcement Communication Training (IMPACT),” at the University of North Carolina. The IMPACT Program Project will make a significant contribution to cancer prevention by developing new, effective strategies to improve provider care metrics. Drs. Justin Trogdon and Tara Licciardello Queen will be the co-leads of the Data Core. The Data Core’s functions include managing a national primary care team survey, cleaning and standardizing effectiveness data across research projects and providing statistical support for randomization and analysis. The three Specific Aims of the Data Core are as follows. Aim 1 is to develop, oversee, and manage the national primary care team survey. The Data Core will survey 2,500 primary care team members: 1,500 physicians, physician assistants, and nurse practitioners and 1,000 registered nurses and medical assistants that see patients ages 9-12 years old. The Data Core will be responsible for coordinating survey measures for use across projects, collaborating with the survey subcontractor to oversee survey implementation, and managing and preparing data for use by the research projects. Aim 2 is to facilitate access to, and standardize the structure of, large health outcome datasets generated by research project randomized clinical trials. The Data Core will be a central hub for managing, harmonizing, storing, and distributing randomized clinical trial outcomes data that will be used to evaluate intervention impact across Projects 1 through 3. The Core will also provide the resulting data to Project 4 to support budget impact and cost-effectiveness modeling. Aim 3 is to provide statistical and methodological support to research projects. The Data Core team will connect project investigators with appropriate statistical and study design expertise to design and consult on analyses as needed by the research projects. The Data Core activities will result in a national primary care team survey, high-quality, standardized data and appropriate and rigorous statistical analysis in an efficient manner that will increase the collective impact of the P01 Program Project. The Data Core addresses the IMPACT Program Project theme by helping the research projects build capacity for quality improvement interventions among primary care teams in healthcare systems.

Public health relevance
The Data Core will centralize data-related services across research projects for the P01 Program Project. The Data Core’s functions include managing a national primary care team survey, cleaning and standardizing effectiveness data across research projects and providing statistical support for randomization and analysis.